Expanding early cancer detection with high throughput OCEANA - Ovarian Cancer Exosome Analysis with Nanoplasmonic Array

Ovarian cancer (OvCa) remains the most lethal gynecologic cancer in the United States. Early
detection through screening, particularly of high-risk populations, is an appealing strategy for timely
intervention yet conventional efforts have not improved survival. Extracellular vesicles (EVs; 30-200
nm in diameter) are actively released by cells into circulation, carrying diverse molecular cargo.
Capturing this information could provide a real-time window to monitor tumor burden and dynamic
molecular changes and potentially OvCa precursor lesions. We aim to advance our translational EV
assay for early OvCa diagnosis with a focus on its most lethal subtype, high-grade serous ovarian
cancer (HGSOC). We formed a powerful strategic academic-industry alliance between
Massachusetts General Hospital, Brigham and Women's Hospital, and Exosome Diagnostics and
have laid out two primary objectives. Technology reﬁnement. We will implement an automated and
high-throughput platform, OCEANA (Ovarian Cancer Exosomal Analysis with Nanoplasmonic Array).
We will also construct an EV marker panel to enhance the diagnostic power of EV assays. Expanded
clinical validation. We will rigorously evaluate OCEANA and EV biomarkers using patient-derived
organoids and samples across the clinical spectrum (e.g., benign, early, advanced stages) from a
world-class and gynecologic-focused biorepository. We have four Speciﬁc Aims to achieve these
objectives. Aim 1. We will develop a disk-based cartridge for fast, automated total EV isolation. The
underlying technology will be our dual-mode chromatography (DMC) which has demonstrated
superior EV extraction from plasma. Aim 2. We will establish an expanded EV-marker panel for
HGSOC detection informed by patient-derived organoids and EVs. Speciﬁcally, EV protein and mRNA
results will be combined to make a multi-analyte marker panel. Aim 3. We will analyze EVs from mice
hosting HGSOC patient-derived xenografts to study the relationship between tumor progression and
circulating EVs. Aim 4. We will screen circulating EVs in women with benign or malignant ovarian
conditions, rigorously evaluating OCEANA's clinical performance. Impact. This project will establish
OCEANA as a transformative tool for comprehensive EV analyses. The clinical study will also validate
EVs as a potent circulating biomarker for early detection of HGSOC. Ultimately, we envision
translating the technology as a monitoring tool for cancer care across research and clinical settings.

Public health relevance
NARRATIVE We propose to translate a novel liquid biopsy platform for early cancer detection. Specifically, we will apply a forward-thinking nano-plasmonic platform for comprehensive, high-throughput molecular analyses of extracellular vesicles (EVs). We will rigorously address EVs' clinical utility to detect high- grade serous ovarian cancer in high-risk patient cohorts.